Defining the cell type-specific role of miR-9-2 in telencephalon development

PROJECT SUMMARY
Dysregulation of gene networks during development can lead to organ malformation, dysfunction and disease,
especially neurological diseases such as schizophrenia, Huntington’s and Alzheimer’s disease. Thus, a more
comprehensive understanding of the gene regulatory networks that are active during development of the
central nervous system are needed to better understand disease etiology and treatment. The long-term goal of
this proposal is to define the role of the microRNA miR-9-2 in brain development, function and disease utilizing
in vivo knock-out mouse models. My preliminary data show that loss of miR-9-2 during development results in
severely malformed forebrains in mice in a gene dose-dependent manner. Based on this and previous studies,
I hypothesize that miR-9-2 is a critical regulator of gene networks that instruct neural progenitor proliferation,
differentiation and survival. Here, using a combination of transcriptomic, genomic and histological methods, I
will uncover the genes, genomic regulatory elements and cellular processes regulated by miR-9-2 during brain
development to define the specific role of this important microRNA. Additionally, I will uncover upstream
regulators of miR-9-2 expression by investigating the role of a deeply conserved cis-regulatory element, or
enhancer in modulating miR-9-2 expression during development. The proposed research is significant because
it will provide a comprehensive understanding of the gene networks, cell populations, and brain structures
under miR-9-2 regulation, give insight into the regulation of miR-9-2 expression and inform on the
consequences of miR-9-2 dysregulation that lead to neurological disease.

Public health relevance
PROJECT NARRATIVE Dysregulation of gene networks during development can lead to organ malformation, dysfunction and disease, including neurological diseases such as schizophrenia, Huntington’s and Alzheimer’s disease. Here, I propose to define the genetic networks regulated by the microRNA miR-9-2 at cellular resolution using an in vivo miR-9- 2 knock-out mouse model that presents with severe brain malformation. This project will fill a gap in our knowledge regarding the specific role of miR-9-2 in cell types of the developing brain, its function as a genetic regulator and its contribution to disease.